Administrative and Protocol Management Core

The Administrative and Protocol Management Core (Core A) of this grant will provide administrative support for the four scientific projects and two scientific cores for the program entitled,

Public health relevance
The Administrative and Protocol Management Core will provide administrative, regulatory and fiscal support for the scientific projects which will support the development of film formulation of UC781 and tenofovir as topical microbicides